The Integrated Stress Response in Human Islets During Early T1D

ABSTRACT
The project, Integrated Stress Response in Human Islets During Early Type 1 Diabetes (T1D), hypothesizes that
the activation of the integrated stress response and formation of stress granules is an early cellular response
initiating β cell stress in T1D that determines cell survival and can be monitored in pre- and early-T1D individuals
with minimal invasiveness. A multidisciplinary Team science approach is being taken to test this hypothesis,
collecting a large suite of heterogenous data, such as mRNA, lipidomics, proteomics and immunologic
measurements. Machine learning is being used to extract a multi-biomarker panel to aid in stratifying stress in
human islets and translating these findings to individuals at-risk for T1D and new-onset T1D. Although we are
formatting the multi-omics data for this specific machine learning task within the parent grant, the data being
generated, as well as our data collected from prior collaborations, are not generally AI/ML-ready for general
application of methods. They are however excellent candidates to be used as “flagship” datasets for AI/ML
readiness, both to test novel AI/ML approaches to tackle data pre-processing challenges and to extract molecular
signatures of T1D. These two gaps in analyses are the central themes of two aims. The first aim focuses on the
generation of AI/ML ready omics datasets that are properly annotated to address challenges in sparsity and bias,
such as imputation and batch correction. The second aim focuses AI/ML ready multi-omic datasets to enable
new studies in using machine learning to elicit biomarkers and pathway-level molecular signatures from the data
focused on standard AI/ML methods, as well as those specialized for small sample size. Dataset machine
learning model cards will be utilized to better enable to AI/ML research communities to utilize these datasets in
an efficient manner. For both aims there is a key focus on generating reusable software approaches to generate
data packages that can be directly imported into the most common AI/ML packages and released to the AI/ML
community through a variety of resources that enable feedback to continually improve and refine the AI/ML
readiness software development plan.

Public health relevance
NARRATIVE Machine learning is a core technology that is rapidly advancing within type 1 diabetes (T1D) research. Our Human Islet Research Network (HIRN) grant is studying early cellular response initiating β cell stress in T1D through the generation of heterogenous low- and high-throughput molecular measurements, which are well suited for use as AI/ML ready datasets, as well as the development of generalized software solutions to transform disparate data into common formats with appropriate metadata for AI/ML. The data packages developed will focus formats that can address challenges in pre-processing (e.g., imputation), feature extraction, and other gaps in the processing of single- and multi-omics datasets that can be addressed through AI/ML methods for both small and large sample sizes.